OpenNeuro: An open archive for analysis and sharing of BRAIN Initiative data

Project​ ​Summary/Abstract
The NIH BRAIN Initiative is supporting a broad portfolio of neuroscience research aimed at
revolutionizing our understanding of the brain. ​The sharing of data obtained from this research
is critical both to leveraging this major public investment and to ensuring the rigor and
reproducibility of NIH-funded research. ​We propose to extend to the existing OpenNeuro data
archive in order to provide a platform for the storage, processing, and sharing of neuroimaging
data collected as part of the BRAIN Initiative. OpenNeuro extends the successful OpenfMRI
project by encompassing a broader range of neuroimaging data, and by providing the ability to
run data processing workflows on the data directly on the platform (using cloud computing
resources) and share the results of those workflows alongside the data. The platform focuses
on reproducibility through the use of versioned and containerized analysis workflows that are
applied to snapshotted data releases. The proposed project would provide support for analysis
and sharing of data from BRAIN Initiative projects as well as other interested projects. In
addition to this infrastructure, the aims of the project are to develop a robust semi-automated
curation workflow, implement new tools for federation, query, and identification, and develop
support​ ​for​ ​advanced​ ​data​ ​processing​ ​workflows.

Public health relevance
Project Narrative The NIH BRAIN Initiative is developing research tools that will revolutionize the study of the brain, and one key to maximizing this investment is the open sharing of data collected as part of this research. We propose to implement a data archive for neuroimaging data collected as part of the BRAIN Initiative as well as by other researchers who wish to share data openly. The availability of these data will maximize the ability of researchers to understand the brain dysfunction associated with neurological and mental health disorders.